Optimizing lipid RVn monophosphate prodrugs to maximize RVn-triphosphate delivery

PROJECT SUMMARY/ABSTRACT
Emerging RNA viruses, especially respiratory viruses, are among the leading threats to global health. With few
treatments currently available, there is an urgent and ongoing need for the development of safe, effective oral
antivirals. The objective of this application is to optimize an innovative lipid prodrug delivery strategy for
remdesivir nucleoside monophosphate (RVn-MP), and additional broad-spectrum nucleoside antivirals, to
achieve 1) excellent oral bioavailability, 2) efficient intracellular activation across tissue types, and 3) bypass of
liver metabolism to enhance tissue delivery. The central hypothesis is that specific modifications to the lipid
prodrug scaffold can improve in vivo antiviral efficacy by enhancing prodrug metabolism to the active metabolite
and augmenting tissue delivery. The rationale for this project is that a better understanding of how lipid prodrug
modifications increase antiviral activity will allow for the rational design and development of novel broad-
spectrum oral antivirals for the treatment of clinically important RNA viruses.
Strategy: Aim 1 will identify the mechanisms that determine prodrug antiviral potency in vitro to maximize antiviral
activity. Quantitation of lipid RVn-MP prodrugs and their metabolites in cell culture using mass spectrometry will
determine how scaffold modifications alter uptake, metabolism, and antiviral activity. Genetic knockout studies
will identify the specific phospholipase C (PLC) enzyme/s that are necessary for lipid RVn-MP prodrug
metabolism across cell types. Finally, PLC enzyme kinetic studies will identify scaffold modifications that
maximize metabolism and antiviral activity in vitro. These data will inform lipid prodrug scaffold design that
optimizes lipid RVn-MP potency. Aim 2 will determine how lipid prodrug modifications control distribution to
maximize tissue delivery. First-pass removal of oral drugs by the liver is a common problem in drug development.
We will evaluate how oral lipid nucleoside prodrugs can partition into chylomicrons, move through lymphatics to
the thoracic duct, and thereby avoid first-pass liver metabolism while increasing lung delivery. Structure-activity
relationship studies using a library of lipid RVn prodrugs will identify scaffold modifications that increase intestinal
lymphatic trafficking and improve serum pharmacokinetics and tissue distribution. Scaffolds that maximize in
vitro antiviral activity (Aim 1) and in vivo lung delivery (Aim 2) will be selected to rationally design new lipid RVn-
MP prodrugs and novel lipid prodrugs containing nucleosides with broad spectrum activity against RNA viruses.
New compounds will be evaluated for increased metabolism and antiviral activity in vitro, tissue delivery in vivo,
and efficacy against pathogenic coronaviruses and dengue in mice.
Collectively, this proposal will optimize the antiviral efficacy of oral lipid RVn-MP prodrugs for the treatment of
many clinically important RNA viruses. Additionally, a better understanding of how to maximize the efficacy of
lipid nucleoside prodrug design may be the key to unlocking a whole new generation of broad-spectrum antivirals.

Public health relevance
Project Narrative RNA viruses are a growing public health concern for which there are few safe and effective oral antivirals available. We propose to utilize novel synthetic chemistry to optimize a series of lipid nucleoside prodrugs for enhanced broad spectrum anti-RNA virus activity, oral bioavailability, and targeted delivery to infected tissues. This project is relevant to the NIAID’s mission of developing highly effective oral antivirals to treat RNA viruses of clinical concern, including RNA viruses with pandemic potential.